Mechanism-informed identification of causal enhancer variants

PROJECT SUMMARY
Enhancers are the genomic elements that encode the instructions for the timing, location and levels of
gene expression. The majority of variants leading to disease are thought to reside in enhancers. However,
we do not understand which changes in enhancer sequence are inert variants and which impact gene
regulation and cellular integrity. Identifying the causal variants underlying these changes is critical for
understanding the mechanisms driving the disease, development of novel treatments, better diagnosis
and stratification of patients for different treatment strategies. It is therefore critical that we identify the
causal variants underlying enhanceropathies. However, identifying which variants within an enhancer
contribute to disease is a huge challenge. It is not experimentally or financially feasible to test all likely
causal variants alone or in combinations in every disease and tissue. Therefore, we urgently need
fundamental and generalizable principles to predict likely causal variants. Here we integrate our
mechanistic understanding of enhancers into current approaches to predict causal variants in eQTL,
GWAS, germline and somatic mutation datasets. We will then rigorously test our predictions to determine
if this approach would enable systematic identification of causal enhancer variants.
Enhancers control gene expression by binding transcription factors to specific sequences. My lab has
previously shown that low affinity or suboptimal affinity binding sites are a prevalent feature of enhancers
and that such sites are often overlooked. We have recently shown that the prevalent use of low affinity
sites within enhancers creates a vulnerability in our genomes, whereby single nucleotide changes can
increase binding affinity leading to aberrant gene expression and changes in molecular and organismal
level phenotypes including extra digits and a second beating heart. We now wish to use our approaches
to pinpoint causal variants that contribute to phentoypes within the context of disease and response to
treatment. We will predict causal enhancer variants in two diverse systems: cardiac conduction traits and
within melanoma metastasis and drug resistance. We will test our predictions using highly parallel
functional reporter assays in relevant cell types along with genotype to phenotype studies. We will apply
our approach to eQTL,GWAS, germline and somatic variants. In addition to prioritize causal varaints, and
testing our predictions, we will provide our computational tools for the community to predict and prioritize
causal enhancer variants within their diseases or tissues of interest. The successful completion of this
project will move us closer to understanding the types of changes within enhancers that contribute to
disease and treatment outcomes and could provide a generalizable systematic approach to identify causal
variants that underly enhanceropathies.

Public health relevance
PROJECT NARRATIVE Enhancers harbor the majority of variants associated with disease, but pinpointing causal variants is a major challenge as they are typically embedded within a sea of inert variants. Here we will use a mechanism-informed approach to predict causal enhancer variants associated with phenotypic diversity and disease and test our predictions in two different cell types and genetic disorders. The successful completion of this project will provide a generalizable approach to prioritize enhancer variants contributing to enhanceropathies, moving us closer to understanding how variation within our genomes contributes to disease and treatment response.